Prototype System for AML Digital Twins

Project Abstract
Conventional chemotherapy has reached its limits in treating Acute Myeloid Leukemia (AML),
the most common leukemia in adults. Many patients who receive intensive chemotherapy
followed by allogeneic hematopoietic stem-cell transplant eventually relapse. Therapeutic
results remain particularly dismal for relapsed or refractory and older patients, who are often
unfit for intensive therapies. Several new therapy options with the potential to improve treatment
outcomes have emerged, but they suffer from heterogeneity in responses and a lack of methods
for identifying patients who might benefit from such therapies.
New detailed simulations called Digital Twins are starting to be implemented in many sectors
including engineering, manufacturing, and medicine. Digital Twins are a simulation of a
real-world system or object that allows for experimentation without real-world consequences. A
patient oriented Digital Twin would simulate physiological response or disease and allow for
outcome predictions following treatment.
We propose to build a prototype of the ‘AML Digital Twin’ system (AML-DT), an interactive
system to be used by doctors with their patients in which the patient’s clinical and molecular
data, collected from bone marrow aspirates and peripheral blood, will be used to instantiate a
digital twin model of the patient’s disease. The digital twin will enable the doctor and patient to
explore personalized model-based predictions of drug response, using measurable outcomes in
light of background knowledge generated from publicly available molecular data from AML
patients. Importantly, the AML-DT system will continuously improve by learning from the
experiences of patients and their digital twin models.
The work, conducted jointly with clinician-scientists and computational researchers at the
Institute for Systems Biology, the University of Helsinki, and Tampere University will center on
patient-specific drug sensitivity prediction of venetoclax in combination with azacitidine by
integrating with an ongoing clinical trial, VenEx, that includes ex-vivo patient selection and
molecular data generation from bone marrow aspirates from AML patients in Finland. A
prototype of the AML-DT system will be deployed at the midpoint of the 5-year project period,
coinciding with the completion of the clinical trial. Following assessment of the prototype, further
developments to the AML-DT will be carried out to accommodate other AML therapies and
recommendations made by patient advocates and clinicians.

Public health relevance
Project Narrative The Acute Myeloid Leukemia Digital Twin (AML-DT) system is centered on personalized models that virtually represent a patient's disease; where patients and their doctors work together with an interactive dashboard to visualize dynamic changes in disease trajectory and to explore therapeutic possibilities. The proposed AML-DT prototype system visualizes patient history, makes predictions of disease progression and drug response which can be validated in clinical trials, and gives clinicians and patients a way to make better care plans by providing needed foresight. Our innovative solutions integrate detailed domain-specific knowledge graphs with multiscale dynamical models of the malignancy, providing a foundation for the development of the first AML Digital Twin.